2 OCTYL CYANOACRYLATE TISSUE ADHESIVE FOR ORAL APHTHOUS ULCER

To evaluate the safety and effectiveness of 2-octyl cyanoacrylate tissue adhesives in reducing pain and healing duration in patients with oral aphthous ulcers.